EFFECTS OF PRONE AND SUPINE POSITION IN PRETERM INFANTS

The purpose of this study is to examine the effect of sleeping position on the cardiorespiratory status, growth, sleep and behavior of the healthy preterm (< 36 weeks gestational age) infant. Preliminary data show differences in apnea, bradycardia, and oxygen desaturations based on body position, especially with regard to feedings.